Microglia in the Brain

DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Microglia in the Brain, organized by Beth Stevens and Richard M. Ransohoff. The meeting will be held in Keystone, Colorado from June 12-16, 2016. In the past five years, our understanding of the origins and functions of microglia, the unique myeloid cells of the central nervous system (CNS) parenchyma, has proceeded at such a remarkable pace that it's as if an entirely new CNS cell type had been discovered. Since their discovery 100 years ago, it has been suspected those microglias are implicated in virtually all disorders of the nervous system. Associations of polymorphic variants of microglial genes have now proven this hypothesis. It is therefore rather urgent to engage investigators in developing a coherent account of the present status of microglial origins, physiological functions and aberrant properties in the diseased CNS. This meeting will further the objective of translating new information into research and treatment strategies. In many ways, the salient barriers in the field can be addressed by sharing fundamental understanding of complex organ systems among investigators. Microglial research is now conducted in parallel among three disciplines: leukocyte biology, neuroscience and immunology. Other interested research groups include those studying neurodegeneration; developmental neurological disorders (autism, schizophrenia); aging; neuroimmune disorders; and stroke and brain trauma. Optimal progress can only be realized by bringing together thought leaders and students in these varied disciplines around the common goal of studying how microglia are involved in processes under investigation. The program will incorporate the extraordinary depth and breadth of scientists now examining microglial biology and will highlight cutting-edge imaging and genetic technologies. The concurrent meeting addressing Common Mechanisms of Neurodegeneration will enhance opportunities for interdisciplinary interactions.

Public health relevance
PUBLIC HEALTH RELEVANCE: Microglial cells are one of the most enigmatic and understudied populations in the central nervous system (CNS). The Keystone Symposia meeting on Microglia in the Brain will highlight new data that implicate microglia in many functions required to build and wire the developing CNS ranging from neurogenesis to synaptic pruning, as well as emerging research that implicate microglia in neural plasticity and behavior in the mature brain. The meeting brings together leaders in the field with a common interest in neuron-glia interactions with the goal of fostering collaborative efforts between scientists using different experimental approaches and studying different model systems. A major objective of this meeting is translating new information into research and treatment strategies.